A K63-Ubiquitination Dependent Necroptosis Signaling Network in the Heart

Project Summary/Abstract
Loss of cardiomyocytes by apoptosis and/or necrosis is a hallmark of cardiac ischemic injury, pathological
remodeling, and end-stage heart failure. Although necrosis was traditionally regarded as a passive and
unregulated process, emerging evidence has shifted this paradigm and identified several forms of “programmed
necrosis”, including death receptor-mediated necrosis (termed “necroptosis”), mitochondria-mediated necrosis,
and other regulated necrotic processes. Despite recent progress, how necroptosis is regulated in the heart
remain largely unknown and preventing necroptotic cardiomyocyte death is still an important challenge. Our pilot
studies identified a new K63-linked polyubiquitination (K63-Ub) dependent necroptosis signaling network that
critically regulates cardiac ischemic injury and pathological remodeling. Intriguingly, the K63-deubiquitinase
CYLD (cylindromatosis) was markedly up-regulated, whereas the E3 ubiquitin ligase TRAF2 (TNF receptor
associated factor-2) was down-regulated, in the heart after ischemia-reperfusion injury. Our preliminary results
further identified CYLD and TRAF2 as an activator and a suppressor of myocardial necroptosis, respectively.
Importantly, cardiomyocyte-specific ablation of CYLD attenuated ischemic injury and adverse remodeling by
inhibiting necroptosis. Acute deletion of TRAF2 in the adult heart caused dilated cardiomyopathy by promoting
necroptosis, whereas TRAF2 gene transfer elicited cardioprotection. Mechanistically, we propose a new K63-
Ub dependent necroptotic regulatory mechanism whereby CYLD deubiquitinates TRAF2 and TAK1, disrupts
TAK1-RIP1 interaction, and promotes the necroptotic complex. As an opposing mechanism, TRAF2 acts as an
E3 ligase for TAK1 to inhibit necroptosis signaling. Thus, the reversible K63-Ub (mainly non-proteolytic)
constitutes a new paradigm of necroptosis signaling with important biological implications. We hypothesize
that the deubiquitinase CYLD, in conjunction with the E3 ligase TRAF2, critically regulate myocardial necroptosis,
ischemic injury, and remodeling, thus representing promising therapeutic targets. Aim 1 will investigate the
opposing roles of K63-Ub modifying enzymes CYLD and TRAF2 in regulating myocardial necroptosis and
ischemic injury in vivo. Aim 2 will define a CYLD/TRAF2 mediated, K63-Ub dependent necroptosis signaling
network in cardiomyocytes. Using genetic and molecular strategies, we will investigate the opposing roles of
CYLD and TRAF2 in regulating myocardial necroptosis under basal conditions and in the setting of ischemic
injury. The proposed studies will provide new insights into the molecular regulation and functional significance
of necroptosis in the heart, which has important translational implications, especially given our preliminary results
revealing CYLD/TRAF2 as key necroptotic regulators and promising targets for ischemic heart disease.

Public health relevance
Project Narrative Necroptosis is a new form of programmed cell death that plays a critical role in cardiac ischemic injury, pathological remodeling, and heart failure progression. This proposal investigates a novel K63-ubiquitination dependent mechanism that regulates myocardial necroptosis, ischemic injury, and pathological remodeling, aiming to develop new anti-necroptotic strategies for ischemic heart disease.